Pilot and Feasibility Program

The Michigan Center for Diabetes Translational Research (MCDTR) Pilot/Feasibility (P/F) Grants Program provides critical startup support and mentorship for early-stage MCDTR investigators with high-quality T2 to T4 translational research proposals related to MCDTR research themes. A crucial feature of our successful P/F program has been its ability to stimulate interest in translational research in diabetes across many units of the university including the Medical School, School of Public Health, School of Nursing, School of Social Work, Institute for Social Research, Michigan Institute for Clinical and Health Research, Nutrition and Obesity Research Center, and the Center for Behavioral Solutions to Healthcare Engagement and Access. In addition, our support of multiple types of research casts a wide net, capturing the innovation of multidisciplinary research and facilitating the convergence of multiple research pathways focused ultimately on establishing and maintaining independence for early-stage investigators pursuing academic careers in diabetes translational research. We will continue to advance the P/F diabetes translational research agenda by further promoting research on social and behavioral determinants of health, population health, clinical and translational diabetes research and by establishing new collaborations across departments and divisions within the Medical School and across the campus.